CORE--BIOMECHANICS AND IMAGE PROCESSING FACILITY

The Biomechanics and Image Processing Core will be used by approximately 20 investigators within the research center. The Biomechanics and Image Processing core objectives are to provide four major functions for its investigators. 1. Three dimensional microcomputed tomography scanning and analysis 2. Bone and cartilage histomorphology 3. Engineering design, fabrication and materials testing 4. Development of advanced image processing algorithms for quantitative analysis The objective of the core is to facilitate studies involving the architectural, morphologic, and histologic analysis of hard and soft tissues. The Biomechanics and Image Processing Core facility provides bioengineering expertise, resources and techniques to investigators involved in musculoskeletal research. The availability of the unique microcomputed tomography scanner provides a tool for the three dimensional analysis of structures with resolution between 5 and 50 microns. Access to advanced computer and image processing systems as well as the bioengineering expertise will assist investigators in developing techniques for quantifying a variety of musculoskeletal research variables as well as in the design of specialized experimental techniques. Based on the current usage, it is estimated that 50% of the micro CT, 25% of the histologic facilities, 15% of the materials testing facilities and 30% of the image processing analysis hardware will be utilized by MAC investigators. The core director will spend approximately 5% of his effort towards the direction of the core. Facilities of this core may also be used by investigators from other Multipurpose Arthritis and Musculoskeletal Disease Centers.